Calcineurin regulatory network control of Aspergillus fumigatus hyphal septation

Invasive aspergillosis due to Aspergillus fumigatus is a leading infectious killer of immunocompromised patients.
A significant barrier to developing effective antifungal therapeutics is the lack of knowledge regarding the
regulation of A. fumigatus growth and pathogenesis. We established calcineurin (CN) as a critical phosphatase
required for A. fumigatus hyphal growth, septation, and invasive disease. We were the first to crystallize the
fungal CN complex, and structure-guided inhibitor strategies showed targeting CN effective in animal models.
However, exactly how CN regulates growth and pathogenesis is largely undefined. We demonstrated that the
CN complex, comprised of catalytic (CnaA) and regulatory (CnaB) subunits, is dynamically localized at active
points of growth, the hyphal tip and septum, likely interacting with key effectors at these active points to regulate
septation and hyphal extension. We confirmed that defects in septation and hyphal extension are not mediated
via the CN-dependent transcription factor CrzA or the major CN-binding protein CbpA. Using mutational
approaches, we showed that CN binds to these unknown effectors at the septum via short linear substrate
binding motifs (PxIxIT/LxVP) and CN mislocalization from the septum leads to aberrant septation and stunted
growth, indicating CN’s direct regulatory role. Our recent CN proteomic and phosphoproteomic approaches
uncovered several hyphal growth-related and septum-associated proteins (SAPs) as potential CN effectors. As
a logical next step, we will now define CN’s main function as a phosphatase to orchestrate growth and virulence
via its interaction with these effectors. Our overall objective is to leverage our strong genetic, structural and new
robust proteomic data to define CN specific control. Our central hypothesis is that CN orchestrates invasive
hyphal growth by binding and regulating key effector proteins through phosphorylation-dephosphorylation at the
septum, thereby governing invasive disease. In Aim 1, we will identify key CN signaling effectors at the hyphal
septum by bimolecular fluorescence complementation and affinity assays. Localization studies of the effectors
in CN inhibited/conditional expression/deletion backgrounds will confirm their CN-dependency for function.
Molecular modeling of CN-effector binding and molecular dynamics simulations will guide our targeted mutations
of predicted CN-binding motifs in the effectors to confirm CN-effector interactions. Effector mutants will be
screened for hyphal growth and septation defects to correlate CN-dependent effector regulation. In Aim 2, we
will perform in vivo phosphorylation analyses of the prioritized SAPs by utilizing orthogonal approaches and LC-
MS/MS analysis to gain in-depth insight into specific residues phosphorylated in the respective SAPs in CN
inhibited/deletion backgrounds. Finally, contributions of CN-dependent septal effectors to septation, septal pore
sealing, hyphal extension, and virulence will be validated using an iterative approach of genetic deletion, targeted
mutations, in vitro growth screening, and murine model validation. This study will, for the first time, identify and
define the CN signaling network of novel septal effectors controlling fungal growth and virulence.

Public health relevance
Invasive fungal infection caused by Aspergillus fumigatus is a leading cause of death for patients with lowered immune systems. Despite this high mortality, the fundamental mechanism of how A. fumigatus grows and invades tissue is not understood and this knowledge is critical to improving treatment. We will define the mechanism of how the critical calcineurin signaling pathway interacts with other proteins to regulate fungal invasive growth and disease.